LAMb Request for Single Sided IVC Mouse Racks

Abstract Funds for six racks to accommodate Mouse Individually-Vented Cages (IVCs) requested from Allentown would increase the mouse housing capacity in the VA Puget Sound HCS Animal Research Facility. We have recently added four new investigators at the VAPSHC which increases the overall animal numbers. The ability to efficiently house more mice within the existing space is necessary because we must accommodate the increasing number of mice needed by our investigators. Single sided racks would allow the animal facility to house more mice in smaller rooms by pushing the cage racks against the walls. No additional staff training, facility construction or electrical work will be required.

Public health relevance
Narrative The Veterinary Medical Unit at the VA Puget Sound Health Care System has an animal cage system that features double sided access to the animals. This works in some of the rooms but not in the smaller housing areas. With expanding numbers of investigators using additional mice we are requesting an additional caging system. Single sided racks would allow cages to be placed against the wall, thus using space more effectively. The caging that fits the new racks is interchangeable with the current cages so there would be consistency in animal housing.